Translational Biomarkers Core, Center for American Indian and Rural Health Excellence (CAIRHE)

Title: Translational Biomarkers Core, Center for American Indian and Rural Health Excellence (CAIRHE)

Modified Project Summary/Abstract Section

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

The overall goal of the Translational Biomarkers Core (TBC) of the Center for American Indian and Rural Health Excellence (CAIRHE) is to help COBRE-supported, other Montana State University (MSU), and local/regional investigators pursue multidisciplinary biomedical research by providing facilities, instrumentation, analytical services, and consultation and training on biomarker assessments for diet, lifestyle, mental/emotional health, and chronic disease. Conducting validated biomedical research addressing optimal health is a key research challenge in the Institutional Development Award (IDeA) state of Montana, which lacks a medical school and is home to American Indian and rural populations that face significant health challenges. To address this need, CAIRHE established the TBC in COBRE Phase I to strengthen the biomedical research capacity of its early-career investigators, both current and future, and to support translational interventions and clinical trials that address health. Beyond CAIRHE investigators, the TBC also supports the Center’s close IDeA program collaborator at MSU, Montana INBRE, as well as other public health and biomedical researchers at MSU, and local and regional clinical, industry, and non-academic entities. The use of validated biomarkers is important in translational public health research, including community-based research, because it provides objective evaluation of lifestyle behaviors and linkages to chronic disease and other health outcomes. Within a multidisciplinary, community-based health research center composed largely of social scientists, the TBC’s analytical support of early-career investigators pursuing translational research on optimal health is highly innovative and unique at MSU. COBRE Phase III funding will allow the Core to continue to provide subsidized support to CAIRHE pilot project leaders, with the goal of advancing their research toward R01-level applications. Moreover, Phase III funding will allow the Core to continue building and broadening its fee-based clientele including former CAIRHE project leaders, other MSU investigators, local and regional research partners, and affiliate institutions throughout the Montana INBRE network. This continued growth of fee-paying clientele is essential to the long-term viability of the Core. To meet these objectives, the Core will continue to pursue the following three Specific Aims: 1) Provide and maintain state-of-the-art laboratory instrumentation; 2) Provide lab analytical services for conducting biomarker assessments; and 3) Provide biomarker research consultation and training to investigators. An effective Core is an indispensable part of the Center’s overarching aim to be the state and regional leader in multidisciplinary, community-based health research, thereby improving the health of American Indian and rural communities.